Development of Bifunctional and Light Activated ReACT Bioconjugation Reagents via Nitrone Photoisomerization

PROJECT SUMMARY/ABSTRACT
The unique reactivity of oxaziridines towards methionine sidechains via N-transfer has been
successfully leveraged to make powerful bioconjugation reagents used by numerous research groups.
However, the utility of this reagent is limited by the difficulty of incorporating secondary reactive
handles and a narrow cargo scope due to the harsh synthesis conditions and sensitivity of oxaziridines.
Photoisomerization of nitrones provides a mild method of oxaziridine synthesis. This route to
oxaziridines allows for incorporation of cargo not accessible with current synthetic methods and
presents a powerful way of controlling oxaziridine reactivity using light. This proposal aims to elucidate
quantitative relationships between nitrone chemical structure and its ability to isomerize to
oxaziridines and the resulting oxaziridine bioconjugation reactivity. Nitrone photoisomerization will be
leveraged to synthesize bivalent reagents that incorporate other commonly used click handles. Finally,
the exquisite control over oxaziridine reactivity provided by the photoisomerization will be used to
uncage oxaziridine reactivity in situ for protein modifications. These studies will greatly expand the
utility of this valuable class of bioconjugation reagents.

Public health relevance
PROJECT NARRATIVE This proposal aims to expand the utility of oxaziridine bioconjugation reagents by leveraging nitrone photoisomerization to oxaziridines. The chemical stability of nitrones and mild photoisomerization conditions can enable access to bivalent oxaziridine bioconjugation reagents that expand the cargo compatible with this chemistry. Furthermore, nitrone photoisomerization can be used to control oxaziridine reactivity in situ for light activated bioconjugation.